1/11 Integrative Neuroscience Initiative on Alcoholism

PROJECT SUMMARY
This is a competing renewal application for the Integrative Neuroscience Initiative on Alcoholism (INIA)-
Neuroimmune consortium (Notice# RFA-AA-20-011, RFA-AA-20-013) to integrate multidisciplinary research
projects based on the genomic, cellular, and behavioral neuroadaptations related to excessive alcohol
consumption. This consortium has identified gene networks and pathways associated with excessive alcohol
drinking in humans and animals and focuses on potential drug targets within neuroimmune and
neuroinflammatory signaling pathways. In the next phase of this initiative, our collective proposals will address
several documented NIAAA goals which include: 1) understanding the genomics, electrophysiology, and
pharmacology of brain immune signaling systems in neurons and glial cells and their role in causes and
treatments of alcohol dependence; 2) using new technologies such as single cell and spatial transcriptomics,
proteomics, and multimodal functional and structural imaging to study these systems; 3) promoting
reproducibility and translation of data through testing in multiple laboratories and in multiple assays; 4) guiding
investigators in determining the translatability of their findings for preclinical and clinical studies by NIAAA-
supported units outside the consortium. The overall hypothesis for INIA-N is that systematic analysis of
neuroimmune mechanisms will inform strategies for treatment of excessive drinking associated with Alcohol
Use Disorder. Ten Research Components and an Administrative Core comprise the consortium. INIA-N will be
directed by the Administrative Core in cooperation with the Executive and Steering Committees and guided by
a distinguished Scientific Advisory Board. The Administrative Core will provide leadership, oversight of
scientific projects, and integration and translation of project data. INIA-N has six goals: 1) expand gene
expression datasets with results from single nuclei sequencing and spatial transcriptomics to generate cell-type
specific and anatomical transcriptome maps and integrate human cellular transcriptome data with human
genome wide association studies; 2) define the contribution of specific non-neuronal cell types (astrocytes and
microglia) to the molecular and behavioral effects of excessive alcohol consumption through a collaborative
investigation of immune related cells of the brain; 3) examine alcohol-induced changes in perineuronal nets
and in the abundance and post-translational modifications of extracellular matrix proteins as mechanisms for
glial-neuronal cross talk that impact brain circuits regulating alcohol consumption; 4) pursue biochemical and
electrophysiological studies of cytokine signaling to understand innate immune mechanisms by which
excessive alcohol consumption changes brain function; 5) apply systems-level, connectomics approaches to
identify mechanisms by which excessive alcohol consumption changes whole brain function, with emphasis on
the role of our top neuroimmune genes; and 6) propose and prioritize drug targets and compounds for
advancement to testing in animals and in humans by NIAAA supported entities outside the INIA-N consortium.

Public health relevance
PROJECT NARRATIVE INIA-Neuroimmune is a multi-disciplinary, highly collaborative research consortium that studies immune and inflammatory pathways in the brain, combining novel genomic and systems-level analyses to identify potential treatments for alcohol use disorder. The closely integrated approach using multiple levels of evaluation, from computational to behavioral, will provide key information about genes and biological pathways that contribute to excessive drinking and will identify candidate drug targets for developing new treatments.